Semi-synthetic Biomaterials for Skin Wound Healing

Supplemental Request under PA 18-906 this document not needed

Public health relevance
Supplemental Request under PA 18-906 this document not needed